Integrating HIV and hEART health in South Africa (iHeart-SA)

ABSTRACT
Our multidisciplinary, multi-country team of implementation science experts propose to adapt, implement, and
evaluate the “Integrating HIV and hEART health in South Africa” (iHeart-SA) program that incorporates
hypertension (HTN) and diabetes (DM) screening and treatment for people living with HIV (PLWH). SA is the
epicenter of the HIV pandemic worldwide with over 7 million PLWH, of whom ~5 million are treated with anti-
retroviral therapies (ART). ART rollout has two relevant repercussions: first, PLWH now have approximately
twice the risk of developing HTN, DM, and cardiovascular disease (CVD); and second, the success of ART
programs creates a corresponding mandate to deliver integrated, high-quality, sustainable treatment strategies
to detect, treat, and control HTN and DM in HIV care. There are patient-, provider-, and system-level barriers to
achieving these goals; but, there are also evidence-based interventions to address them, and we have
extensive experience applying these to transform care for CVD co-morbidities in South Africa and India. We
have determined the barriers to CVD care and reviewed the literature to select a package of interventions
proven successful in randomized controlled trials, including: use of non-clinician care coordinators to support
treatment documentation and quality improvement (QI); incorporation of home monitoring to enhance self-
management; decision-support tools to facilitate treatment initiation and modifications; and monthly audit /
feedback meetings to support continuous QI. We will use the EPIS framework and partner with government,
academic, facility, and community stakeholders to guide the project by: Exploring (engaging stakeholders in
human-centered design to co-adapt the intervention package to align with local capacity, opportunities, and
motivations, Aim UG1); Preparing (strengthening capacity in implementation science, Aim UG2);
Implementing and evaluating the intervention package via a stepped wedge cluster trial and assessing both
implementation (e.g., reach, adoption, fidelity) and effectiveness (e.g., controlled blood pressure [primary
outcome] among PLWH and HTN), Aim UH1; measuring Sustainability and costs after 24 months (where 12
months were spent transferring delivery from study to local staff (Aim UH2); and developing a strategy to scale
up to rural clinics and nationally (Aim UH3). The overall goal of this project is to employ rigorous empirical
methods to develop and test care innovations that expand the scope of HIV care in a sustainable, scalable,
and impactful way. We will employ an achievable milestone plan to deliver high quality outputs, including:
continued stakeholder relationships and co-ownership of the study over the project period; completion of three
PhDs in implementation science; and disseminating findings via high-impact publications and presentations.
We will also participate in NHLBI’s collaborative multi-institution network designed to strengthen research
methods and impacts across all sites, and to advance training of the next generation of scientific leaders.

Public health relevance
NARRATIVE People living with HIV around the world have longer lives and are increasingly being diagnosed with hypertension and diabetes which increases their risk for heart disease and stroke. Although there are established guidelines for hypertension and diabetes care, in South Africa, where nearly five million people are receiving treatment for HIV, patients, providers, and health care facilities have not been equipped to address the added challenges of managing these co-morbidities. Our team has strong partnerships with and experiences of supporting clinics and other stakeholders in South Africa to identify new ways of delivering care that overcomes these challenges and addresses patients’ HIV and heart disease risk factors together; in this proposal, we will adapt, implement, and evaluate a package of these proven interventions to improve hypertension and diabetes care within HIV clinics in South Africa and see if they are appropriate and used by clinics and their staff over a 3 year period in a large project in South Africa.